Homologous Recombination in Genome Stability and Tumor Suppression

DESCRIPTION (provided by applicant): The objectives of this proposal are to determine the roles for homologous recombination in genome stability, tumor suppression, and normal development. Chromosomal instability is a major hallmark of many cancers, and chromosome aberrations can be important prognostic markers, with greater instability usually corresponding to poorer outlook. Unfortunately, the underlying molecular mechanisms that prevent or promote chromosomal instability remain largely unknown. Growing evidence implicates unrepaired DNA double strand breaks (DSB) in genome instability. Homologous recombination (HR) represents one critical DSB repair pathway that may be especially important as cells are multiplying. Our central hypothesis is that homologous recombination is crucial for preventing cancer-related genome instability in rapidly dividing cells. We will test this hypothesis by focusing on the function of one important HR pathway component, XRCC2, in lymphocytes. Using a lymphocyte culture system amenable to both in vitro and in vivo studies, we recently showed that XRCC2 is required for normal B-cell development. We will employ this same system to now carry out the specific aims of: 1) Testing the extent to which XRCC2 prevents replication-associated genome instability and tumorigenesis. Using both in vitro and in vivo approaches, we will test Xrcc2-defective cells for spontaneous or induced chromosomal abnormalities, and measure the effects of Xrcc2-deficiency on tumor suppression. 2) Defining the mechanisms of interaction between XRCC2 and the p53 protein. Our data indicate a genetic interaction between Xrcc2 and the gene encoding p53 (Trp53). We will use multiple approaches to test whether this involves direct or indirect physical interaction of the proteins. 3) Measuring the functions of XRCC2 in normal lymphocyte development. Our data suggest that XRCC2 has critical functions, not just in preventing genome instability, but also in promoting normal lymphoid development. To better understand the mechanisms of tumor suppression, we will precisely define the normal lymphoid developmental roles of XRCC2, using in vitro and in vivo approaches. This work will be essential to understanding the molecular origins of chromosomal abnormalities and how they may function to drive cancer development. PUBLIC HEALTH RELEVANCE: Chromosome aberrations are a hallmark of human cancer, and can be useful indicators of patient prognosis. In this proposal we will investigate the origins of cancer-related chromosome aberrations and the mechanisms by which they occur. Identifying these mechanisms will be key to designing better cancer diagnostic tests;refining prognostic markers;and developing new cancer therapies based on tumor-specific properties.

Public health relevance
Relevance to Public Health Chromosome aberrations are a hallmark of human cancer, and can be useful indicators of patient prognosis. In this proposal we will investigate the origins of cancer-related chromosome aberrations and the mechanisms by which they occur. Identifying these mechanisms will be key to designing better cancer diagnostic tests; refining prognostic markers; and developing new cancer therapies based on tumor-specific properties.